Administrative Core

PROJECT SUMMARY
The Administrative Core will be responsible for overseeing the establishment of the Integrative Center for
Precision Nutrition and Human Health COBRE at the University of Hawaii at Manoa (UHM) and ensuring its
overall success, growth and sustainability. Consisting of the COBRE Director, Program Coordinator, Executive
Committee and Mentoring Teams, the Administrative (Admin) Core will provide comprehensive logistical and
administrative support for the individual Research Projects and Research Project Leaders (RPL), the Core
facilities, and in conjunction with the Community Engagement and Outreach Core (CEO), the Community Pilot
Project Program and Outreach. The Admin Core will be responsible for the ongoing evaluation, assessment
and corrective actions within the COBRE, planning and coordinating the External Advisory Committee (EAC)
meetings and communicating with the External and Internal Advisory Committees (IAC), preparing Annual
Progress Reports, and coordinating all interactions with NIH program officials related to the COBRE. Working
with the Fiscal and Human Resources Departments at JABSOM, the Admin Core will oversee management of
the budgets and annual fiscal reports, equipment maintenance and inventories, and employee records. The
overall goals of the Admin Core are to oversee the successful development and implementation of a
sustainable Integrative Center for Precision Nutrition and Human Health at UH, through the processes and
interactions necessary to carry out the duties and responsibilities to accomplish the goals of the Core. The
goals of the Admin Core will be achieved through the following three Aims: Aim 1: To develop and implement
strategies for efficient, effective management of administrative, fiscal, and scientific aspects of the Center; Aim
2: To develop mentoring strategies that foster scientific and professional development of Research Project
Leaders to ensure their attainment of independent investigator status and R01 or equivalent funding; Aim 3: To
establish and implement a COBRE Pilot Project Program to support research proposals. The Admin Core will
have achieved its goals if it is successful in establishing the foundation and enhancing the research
infrastructure and environment that fosters the development of a cadre of extramurally-funded future leaders in
Precision Nutrition research.